Role of SIRT3 in melanoma development and progression

Melanoma, one of the deadliest cancer of skin, arises from melanocytic cells that are responsible for
melanin production. Recent advances in the understanding of melanoma biology has led to the development of
targeted therapies with promise. For example, BRAF inhibitors vemurafenib and dabrafenib achieved
significant improvement over chemotherapy and were approved for metastatic melanomas with BRAF-
mutations. More recently, the combination of dabrafenib with MEK inhibitor trametinib demonstrated improved
progression-free survival, compared to monotherapy, and has received approval from the US FDA. However,
even with the combination treatment, most of the patients develop acquired resistance, thereby failing to
achieve lasting tumor regression. Therefore, novel target-based approaches are needed for the management
of melanomas. The mammalian sirtuins constitute a family of seven known members (SIRT1 – SIRT7) with
NAD+-dependent protein deacetylase and/or ADP-ribosyltransferase activities]. In addition, they are also
known to regulate post-translational acyl modifications. SIRTs play critical roles in important cellular processes,
and are shown to be involved in the pathogenesis of a variety of diseases, including cancer. The role of SIRTs
in cancer is extremely complex and they appears to have dichotomous functions depending on cell contexts.
Among known SIRTs, SIRT3 is a mitochondrial sirtuin, which coordinates global shift in mitochondrial activity
by deacetylating proteins involved in diverse mitochondrial functions. It also plays important roles in the
regulation of a variety of cellular processes, including transcription, insulin secretion, and apoptosis. The fact
that SIRT3 can regulate several cellular processes which are critical in cancer cell proliferation, makes it a
potential therapeutic target for cancer management. While the research on the role of SIRT3 in cancer is still in
its infancy, studies have suggested its tumor suppressor as well as tumor promoter roles. However, the role of
SIRT3 in melanoma is not known. In our preliminary data, we have found that SIRT3 is overexpressed in
melanoma and its inhibition results in a significant anti-proliferative response in melanoma cells. Further, we
have also found that 4'-bromo-resveratrol (4BR), a new small molecule inhibitor of SIRT3, imparts anti-
proliferative effects in human melanoma cells. Thus, based on available literature and our preliminary data, we
propose to test the hypothesis that SIRT3 plays a critical role in melanoma progression via modulating
p53 signaling, Ku70-Bax interaction and/or cellular metabolic homeostasis. The following specific aims
are proposed: 1) o define the role of SIRT3 in melanoma development and progression, employing a tissue
microarray (TMA) created from retrospective melanoma tissues from veteran patients, and an in vitro cell
transformation model; 2) to define the involvement of p53 signaling, Ku70-Bax interaction, cellular metabolic
homeostasis, as downstream determinants of SIRT3 in melanoma cells; and 3) to determine the therapeutic
significance of SIRT3 inhibition in vivo in 1) Braf-Pten mouse melanoma mode, and patient derived xenografts
(PDX) developed with prospectively collected metastatic melanoma tissues from veteran patients. We expect
that the outcome of studies proposed in this application may define the role and mechanism of SIRT3 in
melanocytic transformation and melanoma progression. This may ultimately lead to development of novel
diagnostic, prognostic or therapeutic approaches for melanoma. Since melanoma incidence seems to be
higher in the veteran population and our proposed study aimed at defining the molecular mechanism of
melanoma development may lead to identification of novel strategies for the management of this deadly
neoplasm. Therefore, our proposed work is relevant and significant to the health care of Veterans and
is in line with the mission of the Department of Veteran Affairs.

Public health relevance
The goal of this study is to define the role and functional relevance of an important protein known as sirtuin3 (SIRT3) in in melanoma development and progression. This study is important because melanoma is one of the deadliest form of skin cancers. Further, several studies have found an increased risk of melanoma in Veterans. The US military currently is, and has been engaged, in missions all over the world, including recently, in the Middle EAST. Deployment to these regions is accompanied with a significant change in the climate, diet, stress and obvious exposures to war related chemicals, which impose increased risk for several diseases, including melanoma. Our study focusing on identification of new gene relevant to melanoma progression may improve therapeutic options for the management of this deadly neoplasm. Therefore, our proposed work is relevant and significant to the health care of Veterans and is in line with the mission of the Department of Veteran Affairs.